Racial/Ethnic Disparities in Ovarian Cancer Treatment and Survival: An Integrative Approach

Project Abstract: This application is being submitted in response to the Notice of Special Interest (NOSI)
identified as “NOT-CA-22-057”. Ovarian cancer is the most lethal gynecologic cancer in women in North
America, yet our understanding of ovarian cancer etiology, recurrence, and survival in Hispanic women living in
Latin America is lacking and our understanding of these factors in US Hispanic women is very limited. To
facilitate the evaluation of the unique pathogenesis of ovarian cancer among understudied global populations,
we will confirm ovarian cancer cases via medical record linkage and through centralized pathology review to
identify the distribution of histotypes in cases from the Mexican Teachers' Cohort (MTC) and compare them
with the Hispanic cases from Kaiser Permanente Northern California (KPNC). We will also determine the
availability of data on clinical characteristics, treatment patterns, and outcomes for ovarian cancer cases
diagnosed in MTC that facilitate future comparative analyses across race and ethnicity subgroups in KPNC.
The KPNC population includes US Hispanic cases as one understudied group of interest and this
supplemental funding to increase global cancer disparities research will support the inclusion of and
comparison with a complementary group of ovarian cancer cases diagnosed among women living in Mexico
from the MTC. Specifically, we will leverage the existing resources available in the MTC, including case
validation linkages and algorithms developed for breast cancer, and apply them to ovarian cancer, to develop
the capacity to evaluate a subset of the parent R01 research aims in the MTC. Importantly the ability to
compare histotype distributions and survival of Hispanic women living in California to women living in a
culturally, geographically, and economically diverse 12-state region in Mexico will improve the generalizability
of our study findings and provide important and relevant data on an understudied and underrepresented
population subgroup. Given that self-reported Hispanic ethnicity represents a diverse group with varying
traditions and cultural backgrounds, we will also evaluate all comparisons with KPNC cases among the
subgroup with self-reported Mexican ethnicity. Strengths of the proposed study include the overlapping study
years for the two cohorts (2000-2018 KPNC, 2006-2022 MTC) and centralized pathology review. Additionally,
this supplement expands our multi-disciplinary research team to include additional researchers with expertise
in complementary areas who are committed to understanding racial and ethnic disparities in ovarian cancer.

Public health relevance
Project Narrative: Ovarian cancer is the most fatal gynecologic malignancy in North America, however our understanding of ovarian cancer in diverse populations is limited. We propose to enrich our current multi- ethnic cohort of ovarian cancer patients in California by evaluating ovarian cancer heterogeneity and the availability of clinical characteristics and treatment data to understand ovarian cancer outcomes in patients living in Mexico. We will compare histotype distributions and ovarian cancer survival for women living in Mexico with US Hispanic ovarian cancer cases from KPNC.